Bio-Imaging and Confocal Microscopy

PROJECT SUMMARY - BIO-IMAGING AND CONFOCAL MICROSCOPY
The Bio-Imaging and Confocal Microscopy Core at OHSU will provide instrumentation and support for
fluorescence and confocal microscopy, as well as rodent optical coherence tomography (OCT) to enhance and
facilitate vision research at OHSU. The major instrumentation and expertise are already in place at the Casey
Eye Institute (CEI). Past P30 support of imaging systems at the CEI has been extremely successful, with data
from the supported instruments featuring in 61 publications during the previous 5-year funding period. Dr.
Catherine Morgans, an expert in confocal and fluorescence microscopy, will continue to serve as Director of
the Bio-Imaging and Confocal Microscopy Core, and Dr. Renee Ryals, expert at rodent OCT, will provide
guidance and training to new OCT users. Training opportunities and access to instruments will be available to
all principal investigators, postdoctoral fellows, and graduate students engaged in vision research at OHSU.